A network-based, mixed methods study to identify and support multiple overdose responders and inform overdose prevention interventions

07. Project Summary
The goal of this proposal is to identify strategies to improve the effectiveness and sustainability of overdose
education and naloxone distribution (OEND) programs for people who use drugs (PWUD). Research suggests
that some PWUD enthusiastically take up the role of “overdose responder”, responding to multiple overdoses
over relatively short periods of time. Others, however, respond to few or no overdoses. We seek to determine
the individual, social network, and contextual factors that influence overdose response behavior, with the goal
of improving support for PWUD who respond to multiple overdoses and identifying intervention targets to
improve the overall capacity of PWUD networks to respond to overdoses among their members.
To answer these questions, we propose a longitudinal mixed methods study with 300 PWUDs recruited in
Reno, Nevada (an understudied Western region), to address the following aims:
1. Identify the individual, social network, and contextual characteristics of OD responders (relative to those
who do not carry or do not use the naloxone they have), including substance use behaviors, size and
composition of social networks, personal resilience factors, and geographic and socio-structural factors.
2. Qualitatively describe the positive and negative experiences of responding to ODs, and identify (a) the
support or services needed by PWUDs to sustainably respond to ODs in their communities, and (b) the
barriers to response among those who do not respond or stop responding.
3. Assess feasibility and acceptability of interventions to improve sustainability and wellbeing of responders,
and increase initiation of response behavior among non-responders.
Supplemental Aim: Collect quantitative and qualitative data to inform an agent-based model (ABM) of PWUD to
test how different OEND program delivery strategies could lead to reductions in fatal OD rates.

Public health relevance
08. Project Narrative Over 100,000 Americans died of drug overdose (OD) between April 2020 and April 2021, a 28.5% increase from the year before. Despite investment in OEND as a key strategy to combat the opioid OD epidemic, and national efforts to expand access to naloxone through funding and policy, OEND efforts remain sub-optimally effective. In the proposed study we seek to answer questions related to the optimal delivery of OEND programs for PWUD by studying the individual-, social network-, and contextual factors that influence overdose response behavior (including carrying and using naloxone), and examine the feasibility and acceptability of interventions to improve OEND delivery and improve health and wellbeing of PWUD.